Lymph node inspired hydrogels for immune cell reprogramming

Summary Abstract
This proposal combines the fields of DNA origami, colloids, and supramolecular hydrogels to develop
biomimetic scaffolds to transform the way we engineer T cells for cellular immunotherapy. Cell therapies
have broad biomedical potential, spanning application areas as diverse as cancer, cardiovascular disease and
autoimmune disorders – but realizing this potential is proving difficult due to significant challenges involved with
producing large numbers of engineered T cells, which is done through an arduous ex vivo process. These
challenges have made T cell therapies among the most expensive medical treatments, costing as much as
$400,000 per treatment and requiring as much as 100 days to produce antigen-specific T cell therapies. Despite
this time and expense, current methods also suffer from a risky ‘one-patient, one-batch’ approach that can lead
to failed or low-quality cell products.
These difficulties are unsurprising since engineering T cells is inherently complex and requires replicating the
sophisticated process by which T cells are programmed in the body. Endogenously, this involves an intricate
dance between T cells and antigen presenting cells within highly specialized lymph nodes. The process is tightly
regulated through subcellular, cellular and tissue-level features within the lymph node, but the way that T cells
are engineered commercially bears minimal resemblance to this process. Efforts to develop more biomimetic
technologies to improve T cell engineering have only focused on individual aspects of this process. Moreover,
current commercial efforts are focused on incremental improvements to the current status quo of ex vivo T cell
engineering, rather than pursuing new strategies to engineer T cells directly in vivo. We propose a new modular
platform technology that mimics lymph nodes, recapitulating the sub-cellular, cellular, and tissue level
cues that T cells would encounter in the body. Our approach uses the unique advantages of DNA origami to
gain nanoscale spatial control over key signaling ligands, and then integrates these constructs into an injectable
supramolecular hydrogel that can be used to program and expand T cells directly in living systems.
I am ideally positioned to pursue this research given my extensive training in multifunctional nanomedicine and
in supramolecular biomaterials, which includes technical expertise in nanofabrication, materials characterization,
mammalian tissue culture, gene delivery, flow cytometry, multiplexed immunoassays, molecular imaging and
preclinical animal work. The prototype design in this proposal will be capable of both polyclonal and antigen-
specific T cell expansion and stands to benefit both ex vivo methods as well as open new horizons for in vivo T
cell engineering. We expect that with R21 funding to develop our prototype, we will obtain R01 funding to pursue
long-term goals using antigen-specific in vivo T cell engineering to treat specific diseases.

Public health relevance
Project Narrative Cellular immunotherapy is transforming treatments for cancer, cardiovascular disease, and autoimmune disorders, but production challenges lead to delays, high costs, and inconsistent final products. This project merges DNA origami, colloids, and supramolecular biomaterials to create an injectable hydrogel that mimics lymph nodes, where T cells are naturally trained and expanded. We hypothesize that this lymph node mimicry will enable our hydrogel to be used for in vivo T cell engineering, revolutionizing current cell therapy approaches.